2023 Drug Metabolism Gordon Research Conference and Gordon Research Seminar

Abstract
The field of Drug Metabolism is focused on defining and mechanistically understanding the Absorption,
Distribution, Metabolism and Elimination (ADME) properties of a molecule. ADME has a tremendous
influence on efficacy, safety, and dosing of therapeutic molecules and novel modalities, beyond small
and large molecules, are amongst the medicines of today and tomorrow. The 51st Drug Metabolism
GRC will focus on the challenges and opportunities of the next 50 years of ADME science. Emphasis
will be on cutting-edge science and the importance of interconnectedness among ADME disciplines so
that we fully tap into the potential of emerging technologies and novel approaches in discovering,
developing, and safely using medicine from diverse modalities. The conference will bring together
academic, industry and regulatory scientists at all career stages and provide a stimulating and
collaborative environment to discuss unpublished research and learn about the ADME challenges of
diverse modalities. The informal venue of the Drug Metabolism GRC provides an ideal environment to
establish this. This conference will provide a forum for early career scientists to expand their scientific
breadth, interact with leaders in the field, establish future collaborative relationships, and consider
various career paths. A Gordon Research Seminar will precede the main GRC conference, providing a
unique environment for students and early career researchers to present their work, connect and have
access to mentoring. Attendees will be exposed to cutting edge presentations by world-class speakers
to stimulate new ideas and collaborations with focus on diversity and connectivity driving translational
ADME science so that new treatments and cures can be delivered to patients faster. The lectures are
held in the mornings and evenings over 4.5 days with the afternoons available for informal discussions
and recreation. GRC meetings are small and designed for more discussion time during both the formal
scientific sessions and during informal interactions (e.g., poster sessions, mealtimes, afternoon outings).
To facilitate ample opportunity to discuss their work, the Drug Metabolism GRC organizes four, two-hour
poster sessions, with each poster presenter (at least 60) available for discussion during two sessions.

Public health relevance
Project Narrative The 2023 Drug Metabolism Gordon Research Conference (GRC) is titled “Diversity and Connectivity in Progressing ADME Science: Novel Approaches and Emerging Technologies In Silico, In Vitro and In Vivo”. The conference will focus on cutting-edge science and translation of ADME data through mechanistic understanding and modelling & simulation to aid in discovering, developing, and safely using medicine from diverse drug modalities.